Core F: Genetic and Genomics

The Mount Sinai Alzheimer Disease Research Center (MSADRC) continues its historic success in research by using its unprecedented resources and expertise to seize opportunities for innovative approaches to understand, treat, and ultimately prevent the earliest signs of cognitive loss due to Alzheimer's disease (AD) and other causes of dementia. We have conducted critical basic translational and clinical studies to characterize cognitive loss and dementia in the elderly. We have used the National Alzheimer's Project Act (NAPA) as a road map to focus our established strengths. We continue our commitment to therapeutic development with innovative and powerful systems biology approaches to establish networks that can identify new targets and select trial ready candidates through pharmacological repurposing and by using the novel opportunity offered by our role in the international stem cell consortium, to develop neural progenitors, approaches to find unique models for therapeutic targets. We will develop a trial ready registry of nondemented elders who are informed and eager to participate in prevention studies. We will expand our characterization of racially and ethnically diverse elders currently underrepresented in research, and ensure the opportunity for them to participate in clinical research fully, including genetic analysis, biomarker studies, and clinical trials. We will continue to collect brains from our well- characterized clinical populations and focus our efforts on the pathology associated with the transition from normal aging and cognitive impairment. Contributing to National Alzheimer's Coordinating Center resources with clinical, neuropathological, and neuroimaging data will be continued as well as our commitment to provide the National Cell Repository for AD with samples for every eligible participant in our cohort. In keeping with the recommendations of NAPA and the 2013 AD-Related Dementias Research Workshop to include in the study of AD- related disorders a specific focus on the contribution of vascular risks, we will build on our expertise by proposing 3 projects that focus on the intersection of type 2 diabetes (T2D) one of the most common comorbidities of the at risk age group of AD. Together these efforts are aimed at identifying targets for intervention and prevention of AD. In this revision application we are adding a new Genetics and Genomics Core (Core F) to the P50. The main goals of this core are to provide a bank of biospecimens from ADRC participants and to centralize an integrated database of genomic data for ADRC subjects. Secondly, we will begin collecting longitudinal biospecimens for future biomarker studies in peripheral monocytes. The resources of the cores and opportunities of the projects support the multidisciplinary studies of the widest community of researchers in cognitive loss and dementia.

Public health relevance
Overall Project Narrative Alzheimer's disease (AD) is the most common form of dementia but has no effective prevention or treatment. Understanding the clinical trajectory and the underlying pathogenic mechanisms of Alzheimer's disease is essential to the development of treatments for AD. The Mount Sinai ADRC is focused on understanding the relationship between type 2 diabetes and future development of AD. In this supplement we are adding a new Core to the Center focused on Genetics and Genomics. This Core will provide the research community with biospecimens and genomic data from cognitively normal aged individuals and individuals affected with Alzheimer's disease or related dementias.